Nutritional Omics of Pulmonary Function Decline

PROJECT SUMMARY/ABSTRACT
The goal of the proposed research is to discover genetic and epigenetic factors that underlie lung function
decline in middle-aged to older adults, including factors that interact with omega-3 fatty acids (ω3 FAs),
which attenuate lung function decline. We will identify genetic variants and epigenetic (DNA methylation,
DNAm) biomarkers associated with lung function decline, map genetic variants underlying DNAm
differences, and extend the genetic and epigenetic associations to clinically defined chronic obstructive
pulmonary disease (COPD). Results will add knowledge of the pathophysiology that precedes COPD.
Accelerated decline in lung function, as measured by pulmonary function tests (PFTs), often precedes a
diagnosis of COPD─the 4th leading cause of death in the United States. The decline in PFTs over time is
influenced by environment (e.g., cigarette smoking is harmful, and ω3 FAs are beneficial) and by genetics
(average heritability of 38%). Genome-wide association studies (GWAS) of PFTs measured at a single time
point (reflecting both lung development until early adulthood and decline thereafter) have identified 270+
genetic loci from amassing large sample sizes. Yet, evidence that these loci influence PFT decline in adults
is limited, and definitive associations have eluded the few smaller-scale GWAS of PFT decline.
Gene-environment interactions are likely key to the etiology of PFT decline. We will model interactions of ω3
FAs concentrations in blood (“[ω3 FAs]”) to find genetic variants and blood-based DNAm biomarkers
associated with PFT decline and test whether the associations reflect risk factors for COPD, as follows:
Specific Aim 1: Conduct GWAS and genome-wide joint meta-analyses of variant and variant × [ω3 FAs]
interaction for PFT decline.
Specific Aim 2: Identify DNAm biomarkers for PFT decline and map cis-methylation quantitative trait loci
(cis-meQTLs), accounting for [ω3 FAs] interaction.
Specific Aim 3: Extend associations for PFT decline to COPD, accounting for [ω3 FAs] interaction.
Aims 1─2 will be carried out across general population cohorts: Cohorts for Heart and Aging Research in
Genomic Epidemiology, SpiroMeta, and UK Biobank (total N=60,586). Aim 3 will leverage the COPDGene
cohort of clinically defined COPD cases and controls. Our integration of GWAS, DNAm, and [ω3 FAs] and
extension to COPD will greatly improve the likelihood of meaningful discovery by identifying factors with high
biological and clinical relevance. PFT decline-associated genetic variants and DNAm biomarkers, including
ones that interact with [ω3 FAs] to attenuate decline, may provide specific targets for developing intervention
strategies, such as tailored dietary guidance or new druggable targets, to prevent or delay onset of COPD in
people with steeper PFT decline due to genetic risk or environmental insults (e.g., smoking).

Public health relevance
PROJECT NARRATIVE This project will integrate data on genomics (DNA sequence variation), epigenomics (DNA methylation), and ω3 fatty acids to study their effects on lung function decline in adults from the general population and on chronic obstructive pulmonary disease. The project aims to discover new genetic and epigenetic associations with lung function decline, including associations that differ by levels of ω3 fatty acids. Results of this project may highlight intervention strategies, such as personalized dietary guidance or new drug therapies, to slow decline and prevent or delay onset of chronic obstructive pulmonary disease.